Consequences of combined prenatal alcohol exposure and acute placental ischemia on frontal cortical-sensitive behavior, structure, and physiology in juvenile offspring

PROJECT SUMMARY / ABSTRACT
Abnormal placental blood flow significantly increases the risk of fetal morbidity and mortality. Placental
insufficiency (PI) occurs in as many as 6% of pregnancies in the United States and can result in
neurodevelopmental abnormalities. Heavy prenatal alcohol exposure (PAE) increases rates of placental
dysfunction, but the impact following moderate PAE is less clear. More than 5% of infants born in the United
States have PAE, which can result in severe long-term neurodevelopmental deficits, including cognitive
impairment, language and motor disabilities and attention disorders. Although it is known that PAE or PI each
result in brain injury, the impact from the combination of PAE and PI on neurological outcomes is poorly
understood. As there are currently no clinical methods to diagnostically or prognostically stratify infants with this
combination of conditions, this study fills a gap in knowledge on the interaction between PAE and PI and their
cumulative effects on the developing brain. Our central hypothesis is that: Moderate prenatal alcohol exposure
exacerbates the impact of acute placental insufficiency on behaviors sensitive to medial frontal cortical functional
and structural damage in juvenile offspring. In Aim 1, we will test whether touchscreen testing reveals greater
deficits in attention to target stimuli and the ability to withhold responding to non-target stimuli in the PAE+PI
compared to either insult alone. In Aim 2, we will examine whether the combination of PAE+PI reduces fractional
anisotropy, increases tensor diffusivity, and alters dendritic morphology and spine density in the cingulate cortex
at Postnatal day 35 (P35). We predict that PAE+PI will result in significantly decreased branching more so than
in PAE or PI alone. Finally, we will test whether PAE+PI alters patterns of neuronal firing and oscillatory activity
within the cingulate cortex in Aim 3. We predict that PAE+PI will result in decreased firing rate in cingulate cortical
Layer 5 pyramidal neurons, a compensatory increase in the number of task-responsive single units and a
decrease in the coherence of oscillatory activity. Together, these studies will examine both the microstructural
and functional abnormalities during a critical period of neurodevelopment and could provide vital translational
clues to the specific functional brain damage caused by PAE and PI. Completion of this investigation could
lead to mechanistic studies providing important insights on if alcohol consumption can exacerbate the
neurobehavioral consequences of a relatively common placental complication in late pregnancy.

Public health relevance
PROJECT NARRATIVE The co-occurrence of prenatal alcohol exposure and reduced placental blood flow during pregnancy is a relatively common, yet largely unrecognized problem which can diminish a child’s ability to focus and learn later in life. This research project will employ a novel preclinical model combining moderate prenatal alcohol exposure and acutely decreased placental blood flow to investigate the adverse consequences of these combined prenatal insults on frontal cortical brain structure and functions associated with cognition in juvenile offspring.